Allograft inflammatory factor-1 and immune tolerance

Allograft inflammatory factor-1 and immune tolerance
Solid organ transplantation is the ultimate therapeutic approach for many end-stage diseases,
but its long-term success is often limited by chronic immune rejection. In heart transplantation,
this low-grade rejection manifests as cardiac allograft vasculopathy (CAV). The lesions of CAV
characteristically show concentric vascular intimal hyperplasia composed of smooth muscle-like
cells and associated extracellular matrix; this intimal expansion develops diffusely throughout
the vasculature of transplanted organs, eventually limiting their arterial conduit function and
causing graft ischemia and failure.
Allograft inflammatory factor-1 (AIF1), a 17kDa EF hand-bearing protein, is strongly expressed
in peri-arterial macrophages in transplanted hearts, and is also upregulated in multiple
autoimmune conditions. In preclinical studies, forced expression of AIF1 in non-transplant
models of vascular injury increases neointimal and atherosclerotic lesion size, suggesting that
AIF1 acts as a driver of vascular obstruction. AIF1 deficiency, on the other hand, limits disease
activity in experimental autoimmune encephalomyelitis (EAE) and in collagen-induced arthritis,
models for multiple sclerosis and rheumatoid arthritis, respectively. These findings suggest that
expression of AIF1 promotes inflammation and contributes to the pathogenesis of autoimmune
inflammatory processes. How AIF1 induction and accumulation after transplantation affects
CAV and donor organ survival is unknown.
AIF1 has been characterized as a cytoplasmic protein that acts as a scaffold for pro-
inflammatory signaling. It is associated most closely with actin bundling, which plausibly relates
to AIF1-based cytoskeletal effects on macrophage migration and phagocytosis, but the precise
basis for broader AIF1-dependent effects on cell function and inflammation remains nebulous.
In recent studies, we identified novel interactions of AIF1 with proteins that have established
links to immune regulation. Our goals with the proposed studies are to ascertain the nature of
these molecular interactions and how they affect immune cell phenotypes, and to test if AIF1
expression is necessary for the allogeneic response that causes CAV and transplant failure.

Public health relevance
Solid organ transplantation is the ultimate therapeutic approach for many end-stage diseases, including heart and kidney failure. Unfortunately, long term success of many transplants is limited due to recipient immune intolerance – which can manifest as chronic, low level rejection of the transplant by the recipient’s immune system. This smoldering process damages the transplanted organ and eventually causes it to fail. These studies will examine molecular interactions involved in immune system regulation relevant to transplantation. By understanding these interactions, we may be able to devise new therapeutic approaches to modify tolerance, and so improve the long term function of transplanted organs.